Administrative Core

The primary objective of MPC's Administrative Core is to maximize tlie productivity of l\/IPC researchers by reducing administrative burdens. The administrative staff is responsible for the day-to-day operations of the Center and planning for the continued development of MPC. Services fall into the following categories: communications and coordination, human resources administration, administrative support for cores and projects, grants management, and fiscal management.